Communicating Science to the Public to Promote Informed Decision Making

PROJECT SUMMARY/ABSTRACT This research project is designed to assist the U.S. Food and Drug Administration Center for Drug Evaluation and Research's (FDA/CDER's) Office of Communications in meeting the challenges of communicating scientific information to the public, especially about prescription drugs and over-the-counter medications. FDA has already undertaken several activities to enhance its communication strategies to the public about the risks and benefits of the products it regulates. Our research will focus on understanding how adults in the United States may differ with respect to health literacy skills and examine how health literacy and other consumer characteristics may impact the effectiveness of FDA communications. In addition, we will explore and then evaluate how messages and products can be modified to meet the needs of various audience segments. We address the following research questions: (1) What factors influence people's comprehension of medication risk and benefit information and drug-related decisions? (2) What role does the media play in communicating scientific data about medications to the public? (3) Does targeting messages and materials to certain audience segments improve the transmission of scientific information and promote informed decision making? Aim 1 includes conducting a web-based panel survey of 1,300 U.S. noninstitutionalized adults aged 18 to 74 years and then developing audience segments relevant to CDER. Aim 2 contains three simultaneous activities: (a) performing content analysis and media monitoring, (b) conducting formative research with new audience segments, and (c) assessing current FDA outreach and dissemination strategies relative to the CDER Strategic Plan and FDA Strategic Plan for Risk Communication. In Aim 3, we will share findings from Aims 1 and 2 with the FDA/CDER/Office of Communications and then collaborate to develop, implement, and evaluate a pilot study. The pilot study will provide these newly identified audience segments with information about FDA products to help promote more informed decisions about drug safety, medication choices, and adherence. Our expected outcomes from this project are (1) the development of a more nuanced understanding and approach to developing scientific communication about medications, (2) enhanced capacity within CDER for developing communication tools and services that meet the information needs of most U.S. adults, and (3) understanding of how this knowledge can be used to create campaigns through traditional and new media channels.

Public health relevance
PROJECT NARRATIVE In this research project, we focus on understanding how health literacy and other characteristics may influence the effectiveness of FDA communications in achieving public health objectives. In addition, we explore and evaluate how messages about prescription and over-the-counter medications can be modified to meet the needs of various audience segments and promote informed decision making. __SpecificAimsTextDelimiter__ 2. Specific Aims This research project is designed to assist the U.S. Food and Drug Administration Center for Drug Evaluation and Research's (FDA/CDER's) Office of Communications in meeting the challenges of communicating scientific information to the public, especially about prescription drugs and over-the-counter medications. FDA has already undertaken several activities to enhance its communication strategies to the public about the risks and benefits of the products it regulates. Our research will focus on understanding how adults in the United States may differ with respect to health literacy skills and how health literacy and other consumer characteristics may impact the effectiveness of FDA communications. In addition, we will explore and then evaluate how messages and products can be modified to meet the needs of various audience segments. Aim 1: Develop an audience segmentation scheme for FDA audiences. This aim includes conducting a web-based panel survey of 1,300 U.S. noninstitutionalized adults aged 18 to 74 years to assess key characteristics of the public, especially various aspects of health literacy. To ensure that we have sufficient representation of people with low health literacy for segmentation, we will oversample those with less than a high school education. We will use latent class analyses to identify clusters of survey respondents who are similar based on their ability to accurately interpret risks and benefits, preferred sources of health information, medication use, and other related factors. We will use multinomial logistic regression models to identify demographic differences (e.g., gender, age, education, race/ethnicity, marital status, employment, geographic region) across the segments. In addition, we will conduct logistic and linear regression models to compare the audience segments in terms of their degree of engagement with drug-related information, decision making, and health-related behaviors and beliefs. Aim 2: Conduct formative research and evaluate message content and strategies for revised audience segments. This aim comprises three activities. A media content analysis of a sample of 400 newspaper articles, television and radio transcripts, online media stories, blog posts, and web videos will lead to detailed findings and recommendations about messaging, audience segmentation, and strategic communication. We will conduct 12 focus groups with representatives from three to four of the consumer segments identified in Aim 1 to collect in-depth data about how participants currently make drug-related decisions; how perceptions of risk, benefits, and uncertainties influence their decisions related to drug use; and the interactions they have had with health care providers related to their medicines. The third activity will be a communications asset inventory that includes cataloging CDER's current products and vehicles, an examination of the effectiveness of current products and communication channels and activities, and recommendations and opportunities for serving the medication information needs of CDER's current priority audiences and those segments identified in Aim 1. Aim 3: Conduct Pilot Study Using Segmentation and Enhanced Communication Techniques and Dissemination Strategies. In Aim 3, we will share findings from Aims 1 and 2 with the FDA/CDER/Office of Communications and then collaborate to develop, implement, and evaluate a pilot study to provide these newly identified audience segments with information about FDA products to help promote more informed decisions about drug safety, medication choices, and adherence. We will work with CDER to decide which ongoing public education effort to build on, develop new partnerships if needed to reach and serve these new segments, and develop tailored campaign tools and services. We will evaluate the reach and impact of the campaign among selected priority groups. Our expected outcomes from this project are (1) the development of a more nuanced understanding and approach to developing scientific communication about medications, (2) enhanced capacity within CDER for developing communication tools and services that meet the information needs of most U.S. adults, and (3) understanding of how this knowledge can be used to create campaigns through traditional and new media channels.